Centromere identity, strength, and regulation

Project Summary/Abstract
Chromosomes are the functional unit of inheritance and must segregate with high fidelity every time a cell divides.
For eukaryotes, a common mechanism is employed, where sister chromatids are physically attached to each
other and bidirectionally oriented towards poles of the microtubule-based spindle that physically move complete
sets of chromosomes to the daughter cells. This bidirectionally-oriented attachment is mediated by a
proteinaceous structure called the kinetochore, which forms at the microtubule/chromosome interface during
mitosis. The site of kinetochore formation is defined by the centromere. Without functional centromeres,
chromosomes are mis-segregated at cell division, leading to a genetic catastrophe—aneuploidy—in the daughter
cells. Over the last 15+ years, the centromere has been the major focus of our attention, and altogether we have
contributed to elucidating the molecular basis for centromere identity, the epigenetic pathway that propagates
centromeric chromatin in perpetuity, the relationship between epigenetic and genetic information in driving
centromere evolution in eukaryotes, and key steps in the quality control pathway that ensures proper
chromosome segregation at cell division. Over the last ~five years, some of our most important contributions
emerging from MIRA-supported projects have come through harnessing this knowledge to develop new and
powerful types of human artificial chromosomes, and using standard structural biology approaches as well as
solution biophysical approaches to advance our understanding of the proteins that drive chromosome inheritance
at cell division. A major focus for our proposed studies will be to use cryo-electron tomography to visualize the
centromere in its natural chromosomal context. In the first research area, we propose to visualize the centromere
during mitosis. This work will fill a major gap in our understanding of how centromeric chromatin demarcates the
site of kinetochore formation. In the second research area, we will advance our current understanding of how
centromeric chromatin propagates centromere identity by visualizing this part of the chromosome at key steps
through the cell cycle. Altogether, the two research areas will provide answers to vital questions related to how
chromosomes are faithfully inherited through cell division.

Public health relevance
Project Narrative Chromosomal inheritance must be flawless every time the cell divides or else unequal chromosome partitioning in the daughter cells, along with the imbalanced dosage of the genes that they carry, will lead to major medical problems such as spontaneous abortion of embryos and fetuses, birth defects in newborns, and tumor formation and progression in adults. Genome partitioning is controlled by proteins that usually reside on highly repetitive DNA at a single locus on each chromosome. The work proposed here promises to advance our knowledge of how this critical process is performed without error in healthy cells and what particular molecular processes may be to blame when catastrophic loss or gain of a chromosome occurs in disease.